Targeting the Rac1 signaling pathway in malignant melanoma

PROJECT SUMMARY/ABSTRACT
Recent advances in sequencing technology have helped uncover a variety of new driver mutations in malignant
melanoma, including recent discoveries of activating mutations in the genes encoding the guanine-nucleotide
exchange factor PREX2 and its small GTPase substrate, RAC1. Activating mutations in RAC1 are of special
interest, as tumors bearing this mutation are refractory towards current targeted therapeutic agents.
The presence of activating PREX2 and RAC1 mutations in a significant fraction of human melanoma suggest
that such tumors could be vulnerable to small molecule inhibitors that target its key kinase effectors, such as
Group A p21-activated kinases (PAK1, -2, and -3), and phosphatidylinositol-3 kinases, in particular PI3Kβ. In
preliminary studies, we have established that Group A PAKs are critical for oncogenic signaling by RAC1 in a
zebrafish model and in RAC1-mutant human melanoma cells. These effects form the basis for Specific Aim 1,
in which we use a new method for signaling analysis to establish the activity of the entire kinome in RAC1, BRAF,
and NRAS-mutant melanocytes. In Aim 2, we will then test specific PAK and PI3K small molecule inhibitors for
their ability to block the effects growth and survival effects of RAC1, as well as determine likely pathways of drug
resistance by determining the activity of the kinome before and after drug treatment. In the third aim, we will
evaluate a new genetically-engineered mouse model of RAC1-mutant melanoma for use in preclinical studies.
Such a model will provide a clinically relevant system to study RAC1 signaling in melanoblast development as
well as a rapid testing platform to evaluate therapeutic agents in melanoma.

Public health relevance
PROJECT NARRATIVE - RELEVANCE TO PUBLIC HEATH RAC1 mutations are the third most common hot-spot mutation in human melanoma, and are associated with a poor prognosis. p21-activated kinases (PAKs) and PI3Kβ are key regulators of two key signaling pathways downstream of RAC1, and blocking one or both of these pathways may therefore shut off growth and survival signals in RAC1 mutant cells. We have developed unique cell and animal models for studying RAC1 function, and have unparalleled access to small molecule PAK inhibitors currently in clinical development, putting us in a unique position to explore the biological role of PAKs in RAC1-mutant melanoma and to determine whether these enzymes represent suitable targets for therapy.